Alcohol-associated liver disease facilitates lobule scale metabolic reprogramming to modulate regeneration

PROJECT SUMMARY
The mortality rate of liver disease due to alcohol abuse, is steadily increasing, necessitating early clinical
intervention. Current intervention techniques, such as resection and transplantation, rely extensively on the
liver's ability to regenerate. During the normal regenerative course, hepatocytes must not only proliferate but
also metabolically compensate for lost tissue mass. However, during ALD progression, this proliferative ability is
significantly diminished. There are additional detriments at the metabolic level, as zonation, or the spatial
organization of metabolic processes across the liver lobule, becomes dysregulated with many key gluconeogenic
and lipid metabolizing enzymes losing their spatial specificity. To date, little is known about the specific metabolic
events allowing for hepatocellular proliferation during regeneration, and how metabolic reprogramming leads to
diminished proliferation in ALD. Therefore, the goals of this project are to uncover the metabolic
mechanisms driving heterogeneous, zonated hepatocyte populations to tissue mass restoration and to
elucidate the metabolic reprogramming events impairing proper regeneration during ALD progression.
Through this work, we aim to test two hypotheses: (1) during regeneration, at peak cellular proliferation, normally
zonated metabolic gene expression is disrupted, leading to a reduction in metabolically compensating
hepatocytes and a decrease in overall proliferative ability in ethanol-adapted livers; (2) there exists a set of
pathological, zone-specific metabolic reprogramming events that can signify the extent of alcohol-associated,
decompensated liver damage and hepatocyte proliferative ability at each stage of progressing ALD.
The first hypothesis seeks to determine the relationship between spatial regulation and metabolic
functionality of distinct hepatocyte populations during regeneration. This hypothesis will be tested using a chronic
ethanol-fed rat model of partial hepatectomy, in which 70% of the liver is resected, to identify the relationship
between metabolic gene transcription and function of heterogeneous hepatocyte populations, proliferating and
metabolically compensating, during regeneration. The second hypothesis seeks to identify the metabolic
reprogramming events occurring during progressive ALD in human patients. Extensive analyses of metabolomic
and transcriptomic data from human tissue samples with progressing ALD will be performed to test this
hypothesis. Both hypotheses will employ quantitative metabolic modelling approaches to make functional
predictions about the enzymatic behavior of hepatocytes during health and disease, which will be compared to
and tested against collected metabolomics data. Through this work, we seek to elucidate the mechanisms
disrupting the tightly interconnected relationship between metabolic regulation and function during alcohol
adaptation, and determine the metabolic reprogramming events occurring at each stage of progressing ALD.

Public health relevance
PROJECT NARRATIVE Liver disease, with alcohol abuse being the main cause of liver-related mortality, is a major health concern for which surgical intervention, including resection and transplantation, remains the only clinically effective treatment for recovery of full functional ability. Both methods of intervention rely extensively on the regenerative ability of the liver, with distinct populations of hepatocytes proliferating while others metabolically compensate for lost tissue mass, however, during alcohol-mediated liver disease, there is a marked reduction in proliferative ability. The proposed research seeks to determine the metabolic reprogramming events impairing proper lobule scale regeneration in alcohol-mediated diseased livers at single cell resolution, thereby facilitating the discovery of therapeutic targets at the enzymatic level, capable of recovering regenerative ability.